ARFs, ORPs and the control of cell migration

The ADP-ribosylation factors (ARFs) are a family of six small, Ras-like GTPases best known for
their roles in membrane trafficking, where they control the formation of carrier vesicles at
multiple intracellular sites. Over the years, we have defined roles for ARFs and their regulators
(GEF and GAPs) in multiple cellular processes including endocytosis and post-endocytic
trafficking, and integration of ARF function with Rho family GTPases in the control of actin
cytoskeleton dynamics. More recently we have focused our attention on a subfamily of ARF
GEFs comprising three members, IQSec1, IQSec2 and IQSec3, that are unique among the 15
human ARF GEFs in their sensitivity to calcium signaling. We previously reported that IQSec2
controls the postsynaptic trafficking of AMPA receptors in excitatory neurons in response to
calcium influx and defined the molecular basis for mutations in IQSec1 identified in patients
with X-linked intellectual disability. Among the 3 IQSecs, only IQSec1 is ubiquitously expressed.
We determined that IQSec1 controls the trafficking of integrins in non-neuronal cells,
specifically in the disassembly of focal adhesions during cell migration. In this context, we found
that IQSec1 forms a complex with the lipid transfer protein ORP3, that translocates to
ER/plasma membrane contact sites immediately adjacent to focal adhesions, in response to
calcium influx via STIM/Orai1 calcium channels. This was the first demonstration that ER/PM
contacts are essential for adhesion disassembly. We determined that ORP3 has at least two
functions at contact sites – it extracts the plasma membrane phosphoinositide PI4P in exchange
for ER-derived phosphatidylcholine, while also allosterically activating IQSec1, driving
downstream activation of the ARF isoform ARF5. Both lipid exchange and ARF5 activation are
essential for adhesion turnover, but the underlying mechanisms remain unknown. Deciphering
these mechanisms will be the focus of this R35 proposal. Preliminary data indicate that
microtubules, which contact focal adhesions and are necessary for disassembly, are
mistargeted in ORP3-deficient cells. Whether this is due to failure of lipid exchange or ARF5
activation will be investigated, as will the underlying mechanisms. Goals of the project include
identification of novel ARF5 effector proteins that function in this process, defining the
mechanisms through which insertion of PC into the PM leads to adhesion disassembly and
defining the relative roles and possible integration of ORP3/IQSec1 with other proteins that
concentrate at ER/PM contacts.

Public health relevance
Project Narrative Cell migration is an important process that occurs in many physiological and pathophysiological contexts, including embryogenesis, inflammation, wound healing and tumor metastasis. Our published and preliminary data indicate a previously unrecognized role for contacts between the endoplasmic reticulum and the plasma membrane in the migration of metastatic cells. This project seeks to understand the mechanisms by which calcium influx and lipid transfer are coordinated at these sites, and how they regulate cell motility.